Cytosolic Delivery of Tumor Antigens into Dendritic Cells

PROJECT SUMMARY/ABSTRACT
Cancer vaccines have recently emerged as a selective way to activate T cells against cancer. The treatments
are based on peptides, called tumor antigens, derived from peptide sequences in tumors that are immunogenic.
Another class of tumor antigens, called neoantigens, arise from mutations in tumors that have not been detected
by the immune system. These cancer vaccines with tumor antigens or neoantigens can promote antigen-specific,
rather than nonspecific, T-cell activation, by either generating new or amplifying existing immune responses
against tumors. Despite the promising anti-cancer immune responses observed with these treatments, effective
and selective activation of the immune system remains difficult.
Several challenges have limited the translation of cancer vaccines into the clinic: (1) Sufficient uptake of the
antigens by antigen presenting cells is difficult to achieve, which greatly influences whether the peptides are
processed or presented to T cells. (2) Proteasomal processing of the peptides is difficult to predict, which can
result in the formation of peptide fragments, other than the desired antigen, that neither bind to an HLA allele nor
activate an immune response. Antigen delivery systems can play crucial roles in improving cancer vaccines. The
delivery systems can perform two critical functions, which the absence of currently limits the efficacy of cancer
vaccines: promote targeting to dendritic cells (DCs) and facilitate cytosolic delivery.
This proposal describes the development of an anthrax delivery system for delivering tumor antigens. My
overarching hypothesis is that the anthrax machinery is well suited for delivering tumor antigens, because it
can efficiently perform protein translocation. In nature, the delivery system transports toxins into the cell cytosol
that rapidly induce cell death. The main components are easily modified for transporting non-native cargo into
cells, including therapeutic peptides, proteins, and even small molecules. This proposal will develop the
anthrax delivery system with two new features: to target dendritic cells and to deliver tumor antigens. These
features will be developed to enhance tumor antigen activity in vivo (Aim 1) and to shed light on antigen
processing and presentation (Aim 2). The impact of this work will extend beyond developing an effective tool
for tumor antigen delivery. It will also facilitate the identification and study of tumor antigens selective for T cell
activation, which will ultimately lead to the development of better tumor antigens for cancer vaccines in the
clinic and beyond.
The training plan and environment permits the design and study of the anthrax delivery system with the
Pentelute lab (MIT), Irvine lab (Koch Institute for Integrative Cancer Research at MIT), and Wu lab (Dana-
Farber Cancer Institute). The proposed studies will be performed with the equipment and resources available
in these labs, and with the facilities available at the Swanson Biotechnology Center at the Koch Institute.

Public health relevance
PROJECT NARRATIVE Cancer Immunotherapy treatments can reduce tumor sizes at unprecedented rates, but can also cause harm to healthy tissues due to nonspecific immune activation. Cancer vaccines with tumor antigens offer the promise of improving immunotherapy treatments through selective activation of immune cells against cancer. This proposal describes the development of two anthrax proteins for delivering tumor antigens into the cytosol of dendritic cells and for facilitating studies of antigen processing and presentation.